Understanding the Development of Social Disconnection in Youth

PROJECT SUMMARY/ABSTRACT
Extensive research has documented the physical and mental health benefits of social support, yet large swaths
of the population experience social disconnection and do not derive these benefits. Roughly 73% of adolescents
report they needed more emotional support than they received in the past year (1), and 39% of high school
seniors describe themselves as lonely (2). The prevalence of loneliness has increased during the COVID-19
pandemic (3, 4), further highlighting the importance of understanding this phenomenon. Why are so many
adolescents experiencing social disconnection? A key underlying process may be adolescents’ heightened
biological stress reactivity (5), which can profoundly affect their social behavior. Taylor (6) theorized that the
stress response can activate two primary social-behavioral profiles: (a) “fight-or-flight” (i.e., an increase in conflict
or social withdrawal) or (b) “tend-and-befriend” (i.e., an increase in prosocial and affiliative behavior). This theory
raises the possibility that the biological stress response activates behavioral repertoires that either increase
social disconnection or facilitate social connection after stress exposure. However, most prior research testing
Taylor’s model has been cross-sectional and with adults, creating a gap in our understanding of when and
why these profiles emerge in development. Adolescence is a key period during which average rates of loneliness
rise steeply, but we know little about why some youth respond to social challenges with socially distancing
behaviors whereas other youth respond by strengthening their social connections. This project aims to fill these
critical gaps by identifying the biological, personality, and relationship characteristics that differentiate these two
social-behavioral stress response profiles. We hypothesize a vicious cycle whereby some youth who experience
social disconnection will show heightened social-behavioral and physiological reactivity in response to social
evaluation or social exclusion, which fosters further social disconnection. At a biological level, we propose this
cycle is perpetuated by altered oxytocin, adrenocortical, autonomic, and inflammatory activity. We propose both
a new data collection effort and secondary analyses of a rich existing longitudinal dataset to test the two aims of
this project. This project will advance our understanding of the development of social disconnection in youth and
the biobehavioral targets that can be modified to increase social connectedness in adolescence and beyond.

Public health relevance
Project Narrative The proposed research is relevant to public health because social disconnection is a major risk factor for poor physical and mental health and it rises steeply during adolescence. The project is relevant to NICHD’s priorities because it seeks to understand social isolation across development, reveal family-level risk and protective factors for social disconnection, and identify targets for behavioral and biological intervention.